Microglial Responses to Cell-free DNA in Alzheimer's Disease

Project Summary/Abstract
This Mentored Patient-Oriented Research Career Development Award application is for Dr. Lolita Nidadavolu,
Assistant Professor of Medicine in the Division of Geriatric Medicine and Gerontology at the Johns Hopkins
University School of Medicine. Dr. Nidadavolu’s long term goal is to establish an independent research career
in Alzheimer’s Disease (AD) focused on disease-associated changes in innate immune signaling and cell-free
DNA (cf-DNA). To achieve this goal, the candidate has assembled an interdisciplinary team that includes experts
in AD, clinical trials, gerontology, chronic inflammation, microglia biology, and biostatistics. The proposed
research for this Career Development Award addresses the critical need to further understand chronic
inflammation in AD, which may lead to development of novel treatment options targeting inflammation. Microglia,
the resident immune cells of the central nervous system, are major contributors to chronic inflammation in AD.
However, a knowledge gap remains in understanding factors that contribute to microglial activation and
dysfunction in AD. One proposed contributor to AD-associated microglial activation is cell-free DNA, which is
released following cell death processes and can be measured in serum. Prior studies demonstrate that
individuals with elevated levels of cf-DNA in serum have lower cognitive test scores and a higher risk of
developing AD. Additional preliminary evidence shows that patient-derived cf-DNA is sufficient to upregulate
inflammatory cytokines in microglia in vitro. The hypothesis of this proposal is that cf-DNA are associated with
microglia activation and can activate pro-inflammatory pathways known to be upregulated in AD. This proposal
will use serum and autopsy samples from Rush Alzheimer’s Disease Center (RADC) Religious Orders Study
and Memory and Aging Project (ROS-MAP) participants as well as Johns Hopkins Precision Medicine Center of
Excellence in Alzheimer’s Disease (PMCoE-AD) and the Johns Hopkins Older American’s Independence Center
(OAIC) to examine associations between cf-DNA and disease-associated microglial activation. First,
associations will be examined between serum cf-DNA levels and microglia activation (Aim 1). Next, functional
changes in microglia phagocytosis and pro-inflammatory pathway activation will be studied in human inducible
pluripotent stem cell-derived microglia exposed to purified cf-DNA from individuals with AD and normal cognition
controls (Aim 2 and 3). The successful completion of the proposed research will lead to a better understanding
of associations between cf-DNA and microglia activation in AD. Additionally, the collaborations and training in
this Career Development Award will provide the coursework, research experience, clinical trial skills, and
mentorship to solidify the applicant’s expertise as an independent clinician scientist and leader in microglia
function and dysregulation in AD.

Public health relevance
Project Narrative The proposed research is relevant to public health because it is focused on studying a critical step in the development of Alzheimer’s disease (AD), microglia activation, which contributes to inflammation and disease progression. The proposal is designed to examine the contributions of circulating cell-free DNA on microglial activation and chronic inflammation. The proposed research lays the groundwork for clinical studies to identify individuals with AD and chronic inflammation who can benefit from treatments targeting microglia activation pathways.